Administrative Core

ADMINISTRATIVE CORE: PROJECT SUMMARY
The Administrative Core will provide administrative and fiscal management for all projects and cores in this
HIPC program and facilitate and foster collaborative communications between investigators for internal and
HIPC-wide interactions. This core will provide program-specific administrative support including coordinating
frequent interactions between projects, organizing regular monthly meetings of all project and core
investigators and personnel (alternating between electronic and in-person), overseeing expenditures and
invoices, maintaining compliance, and coordinating activities for HIPC-wide events and opportunities, as well
as follow up communications and documentation of the aforementioned activities. The roles of this core
comprise three main service aims. For service Aim 1, the core will provide program-specific organizational
support. The administrative staff of this core, overseen by the Program Director, will provide the necessary
administrative support to coordinate the multiple groups in this program, including organizing regular meetings
between project investigators and advisory groups. The administrative core will also assure regulatory and
training compliance for this program. In service aim 2, the core will implement program-specific financial
management, including the tracking of expenditures by all groups and subcontracts, ensuring timely
submission of invoices, and enabling productive use of funds. In service aim 3, the core will facilitate HIPC-
wide collaborations and initiatives for program investigators by providing specific support for inter-HIPC
projects and submission of institutional opportunity fund applications. Through these aims, the administrative
core will serve an essential cohesive function to coordinate all project and core investigators and activities in
this program.